Platelet alphaIIbbeta3 activation and its therapeutic targeting

Abstract
Platelet integrin αIIbβ3 plays a central and nonredundant role in hemostasis and thrombosis. It is normally kept
in a default inactive conformation in resting free-flowing platelets in the circulation. Despite extensive efforts, it
remains unclear how αIIbβ3 is normally kept inactive in the native membrane environment of circulation platelets
despite the presence of μM concentrations of its physiologic ligand fibrinogen. In response to agonists like ADP
or thrombin, generated at sites of vascular injury, αIIbβ3 rapidly switches to a primed (ligand-competent) state
and engages ligands to initiate the formation of the hemostatic plug, a process that includes platelet aggregation
and clot retraction. How ligand-binding triggers conformational changes leading to platelet adhesion in the full-
length integrin has not been determined. And although much is known about the process of platelet aggregation,
studies evaluating the active state of the integrin during clot retraction are lacking.
Supported by the previous funding cycle, we achieved major advances in the integrin field by determining the
first structures of full-length αIIbβ3 in a new membrane-mimetic environment using cryo-electron microscopy
(cryo-EM). We also elucidated the profound conformational changes occurring when the full-length integrin is
ligand-occupied. These conformational changes are prevented in the full-length αIIbβ3 when bound by new
synthetic ligand-mimetic compounds we developed termed pure antagonists. The pure antagonists were as
effective as current agonistic αIIbβ3 drugs in preventing thrombosis in mice but without causing bleeding, a major
drawback of the agonistic drugs. These advances revealed several unexpected and novel features of the full-
length αIIbβ3 structures that we propose to pursue to establish how this integrin is kept inactive on circulating
platelets, thus avoiding disease. We also propose to take advantage of the unique properties of the pure
antagonists to define the activation state of the integrin in formation of the contracting platelet-fibrin meshwork
during clot retraction. The results from these proposed studies are expected to provide a more complete
understanding of how αIIbβ3 activity is regulated in health and disease and offer new insights into the process
of clot retraction that is key to making the impermeable seal in hemostasis.

Public health relevance
Project Narrative Platelet integrin αIIbβ3 is critical for hemostasis and pathological thrombosis that causes heart attacks and stroke. Use of current parenteral αIIbβ3 inhibitory drugs is limited by serious bleeding, and trials using oral inhibitors have failed due to paradoxical thrombosis, with both bleeding and thrombosis linked to inadvertent receptor activation, underscoring the need for a better understanding of how αIIbβ3 activation is regulated at the structural level. Our recent successes in determining the first structures of full-length αIIbβ3 and the development of unique inhibitors revealed unexpected and novel features of the integrin and its regulation that form the basis for a series of studies proposed to elucidate the role this receptor plays in health and disease.